Impact of a Medical-Financial Partnership Intervention on Parent Mental Health, Perinatal Outcomes, and Child Developmental Risk: A Community-Partnered, Multi-Site Randomized Trial

PROJECT SUMMARY & ABSTRACT
Poverty drives inequities in parent health, birth outcomes, and child development, but financial
interventions in health care are rare. Low income and financial stress increase mental and physical health
risks, chronic illness, preterm birth, child developmental delay, and unmet medical needs. Given that half of
Americans report living paycheck-to-paycheck, financial stress is common, especially in pregnancy and
infancy, with disproportionate impacts on marginalized communities and population-wide consequences for
adult health and child development. While the National Academy of Medicine recommends health systems
address poverty-related social needs in clinical settings, some medical professional organizations have gone
further to recommend anti-poverty income and financial supports as health interventions. This has led to
growth of Medical-Financial Partnerships (MFPs), which are cross-sector service collaborations of medical and
financial professionals to reduce poverty and financial hardship directly as an upstream cause of health risks.
Financial coaching improves income, savings, debt, and financial stress using standard tools and
techniques similar to motivational interviewing applied to supporting clients’ financial goals, but its reach could
be much greater if integrated with clinical care, which nearly all infants and parents routinely access. Our team,
including the national nonprofit financial coaching organization LIFT, completed a community-partnered pilot
randomized trial of clinically-integrated financial coaching in a single pediatric clinic that improved parent
mental health, preventive visit adherence, and income, as well as potentially reducing child developmental
delay risk. Because financial stability in pregnancy protects maternal mental health and child development, the
pediatric MFP intervention’s health impact could be even more effective if begun during prenatal care.
We propose a multi-clinic randomized clinical evaluation of the impact of clinically-integrated financial
coaching on perinatal and postnatal parent mental health and health-related quality of life, infant low
birthweight, child developmental delay, health care adherence, family income, and public benefits use.
We will examine the MFP intervention’s mechanisms by exploring timing and mediation effects across
the pregnancy and newborn periods while assessing implementation factors influencing its success.
We will partner with clinics in the Los Angeles County Department of Health Services network, the second
largest public health care system in the US. This community-partnered study will continue our collaboration
with LIFT, a national nonprofit financial coaching organization, to inform the intervention, as well as a national
external advisory MFP Learning Community for insights on implementation and dissemination. We anticipate
this study will advance the field of clinical interventions addressing social and economic drivers of health,
providing evidence on an innovative approach to reduce inequities in mental health and child development.

Public health relevance
PROJECT NARRATIVE Poverty and financial hardship are drive health outcomes during pregnancy, at birth, in childhood, over the life course, and across generations, but clinical interventions to directly support income and reduce financial stress in health care are lacking, especially during pregnancy and early childhood when poverty is most common. This community-partnered, multi-clinic randomized controlled study will examine the effectiveness of a clinically-integrated and family-centered economic intervention: financial coaching, which has shown economic benefits in community-based settings and improved income, primary care adherence, and mental health in our pilot clinical trial - delivered during prenatal and pediatric health care in terms of impact on parent mental health and health-related quality of life, child birthweight, child developmental delay risk, health care utilization, and family financial and public benefits enrollment outcomes. Mechanisms of this Medical-Financial Partnership intervention’s impact and clinical implementation factors that influence its effectiveness will be explored across clinical settings and life course time points from pregnancy through infancy to inform evidence-based, clinically-integrated financial interventions that could expand the scope of health care for low income children and families.